Boosting IL-12-induced anti-glioblastoma activity via immunotherapeutic extracellular vesicles.

PROJECT SUMMARY
The objective of this application is to develop the career of Dr. Breyne, facilitating his transition to a stable,
independent phase and establishing his research program. He will pursue a rigorous career development plan
to further his training in (i) extracellular vesicle (EV) biology, (ii) immune-oncology, and (iii) professional
development. Progress in these domains will be accomplished through coursework, attendance and speaking at
conferences and workshops, writing last author papers, mentoring others, and leading team efforts. The training
environment is exceptional, and the collaborators are world-class. The K22 Award will give the PI protected time
to generate data for an R01 proposal while launching his independent faculty position.
Once glioblastoma (GB) progresses after first-line therapy, treatment options are limited, and managing recurrent
GB remains challenging. While newly diagnosed GB patients have a life expectancy of ~15 months, it is reduced
to 6 to 9 months after relapse. Recently, localized delivery of interleukin-12 (IL12) has had promising anti-tumoral
effects in patients with high-grade, recurrent GB extending the survival to ~17 months. Our preliminary data show
that intratumoral IL12, together with local expression of a costimulatory factor for cytotoxic T lymphocytes (CTLs)
- 4-1BBL, can induce sustained anti-glioma responses. The objective of our studies is to develop a clinically
relevant strategy combining these factors while expanding our understanding of immune-suppressive resistance
against IL12-induced anti-glioma activity. In Aim 1, we will establish disruptive technology presenting
combinations of immuno-modulatory factors on a single nanocarrier. In essence, dendritic cell (DC)-derived EVs
will be designed to display IL12, 4-1BBL, and a neoantigen:MHC complex. In line with our findings of GB-treated
mice with IL12/4-1BBL combo- compared to IL12 monotherapy, we anticipate that immunotherapeutic EVs will
translate to ~68% improvement in the survival of GB-bearing mice. In Aim 2, the resistance mechanisms induced
by GB against IL12 treatment will be explored. We have observed that myeloid cell subsets sense antitumor
immunity activated by IL12. By combining single-cell RNA sequencing analysis with multiparametric flow
cytometry in IL12-treated GB mouse models, we will uncover the pro-oncogenic signaling resulting in a PD-L1
increase and 4-1BBL decrease. In turn, these targets will be monitored in response to intratumoral EV treatment
anticipating the attenuation of GB resistance. Aim 3 will investigate CTL:DC crosstalk driving IL12 treatment.
CTLs are responsible for IL12-induced anti-glioma activity, as shown by our CD8 depletion experiments.
However, little is known about DCs in an IL12-stimulated GB brain. Transgenic mouse models will aid us by
marking or depleting relevant DCs in the tumor and studying the anti-tumor activity of our engineered EVs.
This unique proposal addresses a crucial and timely unmet need in the field. We plan to engage the therapeutic
potential of EVs to arrest GB progression. This work will undoubtedly provide a strong foundation for the
candidate's independent leadership in brain tumor research.

Public health relevance
PROJECT NARRATIVE Recurrent glioblastoma is associated with poor response to immunotherapy due in part to the immune- suppressive tumor microenvironment. Localized interleukin 12 (IL12) is making progress in therapy for malignant brain tumors by triggering anti-tumor immunity in patients. Our proposal will study IL12-induced anti- and pro-tumoral signaling in GB mouse models and develop a next-generation treatment whereby multi-factorial nanocarriers (extracellular vesicles) sustain IL12-triggered immunomodulating effects.